Clinical Impacts of Heterogeneous Interferon Responses to Viral Infection by Asthmatic Airway Epithelium

Project Summary
Asthma exacerbations among U.S children result in 640,000 emergency department visits and 14 million
missed school days annually. Viral infections trigger the majority of exacerbations in children, of which human
rhinoviruses (HRV) are the most common. The airway epithelium plays central roles in regulating
inflammation, airway remodeling responses, and innate immune responses to infection. The most striking
response of airway epithelial cells (AECs) to viral infection is expression of type I and III interferons (IFN I/III)
and IFN stimulated genes (ISG). Some have reported deficient IFN I/III responses to viral infection by
asthmatic AECs and postulated that deficient epithelial IFN responses to viruses predispose to exacerbations,
whereas others have not observed differences in AEC IFN responses to viruses between asthmatic and
healthy AECs. In our unique cohort of well characterized asthmatic and healthy children, from whom we obtain
bronchial and nasal AECs and conduct mechanistic experiments using air-liquid-interface organotypic culture
models, we have observed significant heterogeneity in IFN I/III responses to HRV and RSV infection. For
example, among our asthmatic AEC donors we have noted associations between high type I/III IFN responses
and lower donor lung function, as well as distinct subgroups of exacerbation prone asthmatics with deficient
IFN I/III responses to HRV. Heterogeneity in AEC IFN I/III responses to viral infections may be explained by
polymorphisms in genes coding for viral sensors and/or key steps in signal transduction pathways upstream of
IFN I and III. The overall goal my research program is to understand how airway epithelial responses
influence viral-triggered exacerbations and airway remodeling mechanisms in asthmatic children. In the
first aim, using primary cells from children with asthma we will test our hypothesis that polymorphisms in
genes coding for viral sensors, and/or key steps in signal transduction pathways upstream of IFN responses,
contribute to heterogeneity in IFN I/III responses to HRV infection by AECs from asthmatic children. In the
second aim, we will prospectively follow a cohort of asthmatic children to test our hypothesis that deficient
AEC IFN I/III responses to HRV are associated with a greater incidence of viral-triggered exacerbations in AEC
donors. In the final aim, we will test our hypothesis that excessively high IFN I/III responses by asthmatic
AECs to HRV are associated with lung function decline among AEC donors, and we will interrogate potential
mechanisms whereby excessively high IFN I/III responses may promote proliferation and activation of lung
stromal cells. The studies conducted in my research program and unique resource of primary airway epithelial
cells from clinically well characterized asthmatic children provide an exceptional training environment for young
investigators dedicated to a career in mechanistic patient-oriented research to learn translational research
techniques to investigate the role of the airway epithelium in pediatric lung diseases and viral infection.

Public health relevance
Project Narrative Using airway epithelial cells from clinically well characterized asthmatic children, we will investigate the regulation of epithelial interferon responses to viral infection and the impacts of excessive or deficient epithelial interferon responses on incident viral triggered asthma exacerbation risk and lung function over time. The studies conducted in my research program, and unique resource of primary airway epithelial cells from clinically well characterized asthmatic children, provide an exceptional training environment for young investigators dedicated to a career in mechanistic patient-oriented research to learn translational research techniques to investigate the role of the airway epithelium in pediatric lung diseases and viral infection.